Bacterial RNAP sigma factor structure and function

In bacteria, the 450 kDa RNA polymerase (RNAP) holoenzyme, comprising the evolutionarily conserved catalytic core (subunit composition α2ββ'ω) combined with the initiation-specific σ subunit, directs transcription initiation. Bacterial transcription depends on a primary σ factor that is essential for viability, as well as alternative σ's that control specific regulons. A major mechanism to control transcription initiation is through regulation of σ activity. Dramatic insights have come from structural studies of σ's and holoenzymes. Nevertheless, many challenges remain. In this competing continuation, we propose studies to further our understanding of σ factor structure and function, and interactions with accessory factors. Specifically, we propose to: 1. Determine the structural basis for σ interactions with the -10 element in the initiation of promoter melting. We will determine crystal structures of complexes between σ and in vitro- selected DNA aptamers that mimic σ/-10 element interactions critical for promoter melting. 2. Map the position of E. coli σ701.1 on the RNAP holoenzyme during different stages of promoter open complex formation. A protein-protein crosslinking/mapping approach (guided by our new structure of σ1.1) will be used. The crosslinking-based data will be combined with existing FRET-based distance constraints to generate structural models of σ701.1 in the context of the RNAP holoenzyme in holoenzyme alone, as well as in closed and open promoter complexes. 3. Structurally and functionally characterize σ/anti-σ complexes: Staphylococcal aureus phage G1 ORF67. S. aureus phage G1 ORF67 binds to S. aureus σA domain 4 and is a potent inhibitor of S. aureus transcription. We will determine crystal structures of complexes between phage G1 ORF67 and S. aureus σA domain 4, and functionally characterize the mechanism of G1 ORF67 inhibition of S. aureus transcription. 4. Determine the structural basis for σN interactions with its promoter DNA. We will determine the crystal structure of a complex between Aquifex aeolicus σN and promoter DNA.

Public health relevance
Transcription is the major control point of gene expression and RNA polymerase is the central enzyme of transcription. Our long term goal is to understand the mechanism of transcription and its regulation. We focus on highly characterized prokaryotic RNA polymerases, which have a high degree of conservation of structure and function from bacteria to man. The σ factors are the key regulators of bacterial transcription initiation. Defective transcription regulation underlies many disorders. For example, many oncoproteins are transcriptional activator proteins. Moreover, the bacterial RNA polymerase is a proven target for antimicrobials, such as rifampicin (or its derivatives), widely used in combination therapy to treat tuberculosis. Bacterial strains resistant to rifampicin arise with appreciable frequency, compromising treatment. Insights into the mechanism of bacterial transcription can lead to new avenues for the development of antimicrobials.